Scalable and Epidemiologically Interpretable Phylodynamics to Recover Heterogeneous Transmission Dynamics

Project Summary
As pathogens are transmitted between individuals, they accumulate mutations, leaving a footprint of the
transmission history in the pathogen genomes. Using phylogenetic methods, we can reconstruct the
transmission history connecting individual cases from these genomes, by reconstructing the relationships of
the pathogens. We can then infer population-level transmission dynamics, from the ancestral relationships of
the pathogens, or phylogenies, using phylodynamic methods.
Infectious disease transmission and disease burden are highly heterogeneous, differing between
neighborhoods, across age, and socioeconomic groups, and racial and ethnic lines. This heterogeneity means
that it is crucial to a) be able to illuminate differential disease burdens and b) account for these heterogeneities
when modeling or forecasting infectious disease outbreaks. Traditional approaches based on reported
caseloads are often insufficient for capturing the full scope of highly heterogeneous transmission dynamics.
Phylodynamics offers a potential solution, as it infers transmission dynamics from the connectivity of cases,
providing an opportunity to disentangle these complex patterns. However, limitations in our available toolbox
prevent us from fully utilizing the vast availability of pathogen genomes to study these complex transmission
dynamics, as current phylodynamic approaches suffer from multiple challenges. With the advent of widely
available sequencing, phylodynamic tools are not computationally efficient enough to analyze the amounts of
data generated at the granular scales crucial to understanding transmission dynamics. Additionally, the model
parameters need to be epidemiologically interpretable to be actionable. In this project, we seek to address
these two points by developing novel approaches to reconstruct transmission dynamics from pathogen
sequence data.
We will develop novel phylodynamic tools to reconstruct transmission dynamics at a granular scale by
integrating neural networks into phylodynamic likelihood calculations that we show in preliminary results to
dramatically improve computational efficiency and scalability. Phylodynamic methods are parameterized by
more or less abstract parameters that either have no direct epidemiological meaning or are contingent on
idealized assumptions about disease spread. We will establish how and when current approaches return
biased results when reconstructing city-scale transmission dynamics, describe how they can be used to
estimate actual disease burden, and test them using SARS-CoV-2 sequence data collected by Kaiser
Permanente Southern California (KPSC) and in the UK over the pandemic. Finally, we will develop ways to
quantify the factors influencing disease burden, such as geography, age, and socioeconomics. We will apply
these tools to KPSC SARS-CoV-2 data, where we can access rich patient metadata to study these patterns.
Our overarching goal is to utilize phylodynamic inference of heterogeneous transmission dynamics to
parameterize complex infectious disease dynamic models and improve prediction accuracy.

Public health relevance
Project Narrative Phylodynamics allows us to reconstruct how individual cases are connected in the transmission history from pathogen genome sequencing data. We will develop and apply novel scalable phylodynamic tools to analyze the abundance of viral sequence data and recover transmission dynamics at a granular scale between age and socioeconomic groups in different neighborhoods. Additionally, we will establish approaches and guidelines to interpret phylodynamic inference, distinguish between local and global spread, and recover true disease burden.